Microdata for Population Dynamics and Health Research

Project Summary
IPUMS is a family of nine integrated databases that comprise the largest and most intensively used data resource
for research on population dynamics and health. IPUMS provides three forms of data access to the research
community. One mode of data access is through a web-based data dissemination system; this form of data
access requires advanced data analysis skills, adequate computing, and specialized research software. Another
form of data access is provided via an online data analysis tool; this form of data access lowers the barriers to
using IPUMS data but does not currently provide access to all of the features of the web-based data
dissemination system. The parent project proposes to redesign data access, including enabling analyses of data
requested via the data dissemination system in the online analysis system. The result will be an enhanced online
analysis tool and broader researcher access to the full suite of features available in the IPUMS web-based data
dissemination system. Given the ambitious goals of the parent award, a private cloud computing solution using
local resources was the most feasible approach.
The purpose of this competing revision proposal is to enhance the cloud-computing component of the project by
exploring and testing the suitability of and costs associated with providing researchers access to the online
analysis system. The project includes two major activities. First, the project will provide primary support to create
and manage user-specific research environments in the cloud. Second, the project will support assessments of
the costs of cloud computing in two public cloud computing environments based on a suite of tests intended to
mimic different researcher usage scenarios. The long-term objectives are to build a data infrastructure that
operates as efficiently as possible while best serving the needs of the research community.
IPUMS reduces costs for the population and health research community by minimizing redundant effort,
simplifying data access, increasing the replicability of studies, and improving data reliability. The availability of
large-scale integrated microdata has opened extraordinary new opportunities for fine-grained contextual
analyses of population dynamics and health, resulting in transformational research across a diverse range of
topics and disciplines.

Public health relevance
Project Narrative IPUMS USA data and the IPUMS database more generally are directly relevant to the central mission of the National Institutes of Health (NIH). IPUMS data are advancing fundamental knowledge about health and population dynamics, and they directly support a vast body of research in one of the key priorities of the Population Dynamics Branch (PDB) of NICHD: Health and Disease across the Lifespan. Exploring and testing the feasibility of public cloud computing to enhance this effort is directly aligned with the NIH Strategic Plan for Data Science which emphasizes the use of cloud computing platforms as a possible strategy for addressing resource and computing challenges associated with managing, storing, accessing, and analyzing large-scale data.